Mechanisms of impaired ESCRT-III nuclear surveillance in ALS/FTD

Amyotrophic Lateral Sclerosis (ALS) and Frontotemporal Dementia (FTD) are two age-related
neurodegenerative diseases that share genetic and pathological underpinnings. Recently, disruptions to the
composition and function nuclear pore complex (NPC) have been identified as a prominent and early
pathomechanism underlying neurodegenerative diseases including ALS, AD/FTD, and HD. As the NPC and
surrounding nuclear envelope (NE) environment critically control fundamental cellular processes including
nucleocytoplasmic transport (NCT), gene expression, and genome organization, NPC and NE homeostasis is
essential for neuronal function and survival. Using induced pluripotent stem cell (iPSC) derived neurons
(iPSNs) and postmortem human CNS tissues, we have recently identified a significant injury to the NPC
characterized by the reduction in specific Nups from the human neuronal NPC that culminates in impaired
nuclear protein import and contributes to the dysfunction and mislocalization of the RNA binding protein TDP-
43, a prominent pathological event in neurodegeneration. This NPC injury cascade is initiated by the aberrant
nuclear accumulation of CHMP7 in sALS and C9orf72 ALS/FTD neurons. CHMP7 is an ESCRT-III protein that
while normally localized predominantly to the cytoplasm, is thought to function primarily in ESCRT-III mediated
nuclear surveillance events. The cell biological events and molecular mechanisms underlying CHMP7’s
contribution to NPC and NE surveillance and homeostasis are beginning to be understood in yeast and non-
neuronal mammalian cells during cell division, NE breakdown, and NPC insertion. However, little is understood
regarding CHMP7’s role in maintaining NPC and NE homeostasis in long-lived, non-dividing human neurons
where NPC components are infrequently exchanged, and NE breakdown does not routinely occur. Our
preliminary data highlight the fact that the molecular events that regulate the nuclear localization and activation
of CHMP7 mediated nuclear surveillance in neurons are not perfectly concordant with those recently identified
in yeast and dividing mammalian cells suggestive of distinct neuronal mechanisms that give rise to CHMP7
initiated pathogenic cascades in ALS/FTD. In the proposed studies, we will employ iPSNs from a large number
of sALS and C9orf72 ALS/FTD patients and appropriate controls and utilize a combination of candidate based
siRNA knockdown, biochemical protein interaction techniques, recently developed and optimized live cell and
super resolution imaging strategies, and expression of a newly generated CHMP7 variant plasmid library.
Collectively, these studies will identify the molecular mechanisms that facilitate the nuclear entry (Aim 1) and
nuclear export (Aim 2) of CHMP7 as well as the initiation of CHMP7 mediated NPC injury (Aim 3) to give rise to
NPC injury cascades in ALS/FTD. Therefore, these studies will provide an essential understanding of the cell
biological and molecular events that facilitate CHMP7 mediated NPC injury in human neurons and provide
insights into therapeutic strategies for alleviating this early and significant pathogenic cascade in ALS/FTD.

Public health relevance
We have recently demonstrated that aberrant activation of CHMP7 and the ESCRT-III nuclear surveillance pathway is an early pathogenic event that initiates NPC injury and impacts downstream TDP-43 dysfunction and localization in sporadic ALS and C9orf72 ALS/FTD. However, the molecular mechanisms that facilitate nuclear accumulation of CHMP7 and CHMP7 mediated NPC injury in ALS/FTD human neurons remain unknown. This proposal will test the hypothesis that cell biological events and protein interactions that specifically regulate CHMP7/ESCRT-III mediated NPC homeostasis in human neurons are pathologically impaired in ALS/FTD.